ACTG 892: EFFECT OF HIGHLY ACTIVE ANTIRETROVIRAL THERAPY ON LEAN BODY

This is an observational 48 week study of lean body mass, appetite, functional performance, and systemic markers of inflammation during highly active antiretroviral therapy (HAART) in subjects co-enrolled in ACTG antiretroviral studies. The study will determine if changes in body composition are related to changes in HIV-1 RNA levels and whether the magnitude of these changes in body composition is quantitatively related to (or predictive of) risks of AIDS-defining complications. One hundred subjects will be enrolled into each cohort: one cohort at a lower body mass (BMI<23) and one cohort at a higher body mass (BMI>=23 to 28 Kg(m2) to assure that the entire spectrum of subjects with various body compositions are proportionally included in the study.